Anti-retroviral drugs to block HTLV-1 transmission in vivo

PROJECT SUMMARY/ABSTRACT
Human T-cell lymphotropic virus type 1 (HTLV-1) is a retrovirus which causes a highly aggressive CD4+ T-cell
malignancy called adult T-cell leukemia/lymphoma (ATLL), the neurological disease HTLV-1-associated
myelopathy/tropical spastic paraparesis (HAM/TSP), and other inflammatory disorders. Treatment of HTLV-1-
associated diseases remain inadequate. Viral transmission occurs by sexual intercourse, infected blood
products, and mother-to-child through breastfeeding. Proliferation of viral infection is first through viral replication
and infectious transmission, followed by subsequent mitotic expansion of infected clones with periodic viral
replication. Our group has shown that clinically approved human immunodeficiency virus type 1 (HIV-1) reverse
transcriptase (RT) and integrase (IN) inhibitors also effectively block HTLV-1 transmission in cells. Pre-exposure
prophylaxis (PrEP) is the use of antiretrovirals for the prevention of HIV-1 in those people who have not yet been
exposed to the virus. The effectiveness of PrEP for HIV-1 is through early inhibition of viral replication, before
infection is established. Unlike HIV-1, antiviral therapies to treat existing HTLV-1 infections is lacking, placing a
higher emphasis on transmission prevention. We hypothesize clinically approved PrEP antiretrovirals will
effectively block HTLV-1 transmission in vivo. Currently, people on PrEP are either prescribed a combination of
RT inhibitors (e.g. Truvada), or a long-acting injectable IN strand transfer inhibitor, cabotegravir (CAB-LA). HTLV-
1 RT has higher fidelity than HIV-1 RT. Together with the difference in replication dynamics, we hypothesize
HTLV-1 will be less likely to develop resistance to antiretrovirals. To date however, this has not been tested. In
this proposal, we will determine the efficacy of PrEP in blocking HTLV-1 transmission in vivo and investigate
whether HTLV-1 will develop resistance upon prolonged exposure to antiretrovirals. The efficacy of PrEP will be
examined in our well-established preclinical rabbit model. HTLV-1 infection of rabbits mimics early infection in
humans and is used to study early viral infection events, persistence, and immune responses in vivo. Rabbits
pre-treated with antiretrovirals (CAB-LA or Truvada) will be intravenously challenged with HTLV-1. Viral load and
immune response against the virus will be measured at weekly time points. Rabbits with breakthrough infection
will be identified and the integrated virus will be sequenced for mutations. The stimulated HTLV-1 immune
response will also be examined. Resistance mutations will be identified and characterized in vitro using chimeric
virus technology and IC50s for the indicated drugs will be determined. Finally, residues critical for drug resistance
will be incorporated into an HTLV-1 molecular clone and subsequent viral fitness and EC50 for CAB-LA and
Truvada will be determined by infectious virus release. The wide usage of PrEP has critical implications for
HTLV-1 transmission. Data concerning the effect of antiretroviral activity against HTLV-1 transmission is severely
lacking. Our study will be the first to test antiretroviral drugs in animal models with HTLV-1 transmission. This
study will inform the efficacy of these clinically approved drugs and the types of resistance that may arise.

Public health relevance
NARRATIVE Human T-cell lymphotropic virus type 1 (HTLV-1) causes severe diseases with inadequate treatments and prevention strategies currently available. We determined that pre-exposure prophylaxis (PrEP) antiretrovirals, effective against HIV-1, can block HTLV-1 transmission in cells. This proposal will determine the efficacy of PrEP in preventing HTLV-1 transmission using our preclinical rabbit model of infection and persistence and investigate potential drug resistance, thus informing future treatments and preventive measures for HTLV-1.